Structural and Functional Analysis of Gene and Protein Sequence Families

Nucleosomes comprise 147 base pairs of DNA wrapped around a histone octamer and are central in coordinating various signaling pathways involved in epigenetic regulation. The molecular recognition of nucleosomes by chromatin factors frequently occurs through the interactions with the nucleosomal and linker DNA, histone tails, histone globular domains and by recognizing their specific covalent modifications. Therefore, elucidating the molecular mechanism of interactions between histone/nucleosome and various chromatin factors is essential for our understanding of the principles of chromatin organization and regulation. Protein interaction networks allow for the large-scale measurements of protein-protein interactions (PPIs) in various cellular compartments of different species, but a comprehensive human protein interactome characterization remains a daunting challenge. Herein, we perform a comprehensive mapping of human histone and nucleosome interactions by systematically analyzing the structural, chemical cross-linking and high-throughput data.
To elucidate the physicochemical properties of human histone/nucleosome interactions, we have constructed three human histone interaction networks including structural, cross-linking, and high throughput interactomes and further explored histone interactions at different levels of granularity: protein, domain and residue-levels. In order to analyze histone associated pathways, we further identify an additional layer of partners which interact with histone-binding proteins and construct so called global histone interactomes. We systemically compare three global histone interactomes (structural, cross-linking, and high throughput) and a very low fraction of overlap (4%) has been observed.
Next, we systemically analyzed and compared topological properties of global structural, cross-linking and high-throughput networks. We showed that the node degree distributions for all three types of histone networks follow a power law since it shows a remarkedly strong linear association between the fraction of nodes and node degree on a log-log plot. In a scale-free network, the majority of proteins represent as low degree nodes and only a small number of proteins act as hubs which play critical roles in mediating the network integrity and connectivity. Therefore, the histone interaction network may be relatively tolerant for the defects in low degree nodes but is vulnerable to the perturbations in the hub nodes, for example, between histones and other hub regulatory proteins. Furthermore, we observed a strong power-law decay of values of clustering coefficients with the increasing node degree. Such observations indicate a high modularity of these networks which have more dense connections between the nodes within the modules compared to connections between different modules.
Using data on binding interfaces extracted from structural and cross-linking interactomes, we have systematically characterized binding sites of all human histone variants. We performed multiple sequence alignments of human histone variants per each histone type and mapped the protein binding sites onto histone sequences using binding interfaces extracted from structural and cross-linking interactomes. Next, to identify the histone binding hotspots, we mapped the number of unique binding proteins for each residue onto the consensus sequences of the alignment using binding interfaces extracted from the structural and cross-linking interactomes. Finally, we systemically analyzed histone binding sites in the context of the full nucleosomes. We collected 26 human nucleosome complex structures from PDB, classified them by functions and map binding interfaces onto the molecular surfaces of nucleosomes. We showed that many binding proteins, with the exception of transcription regulatory proteins, recognize nucleosomes via the localized acidic patches. At the same time, in some cases histones participate in multivalent binding.